Research Education Component

Research Education Component Project Summary
The goal of the Research Education Component (REC) of the Knight Alzheimer Disease Research
Center (Knight ADRC) is to develop a dynamic training pipeline to meet the nation's needs for a diverse clinical
translational workforce in Alzheimer disease and related dementias (ADRD). The REC will accelerate the
career development of trainees along the training continuum by leveraging the rich research and training
resources available at Washington University and with collaborators nationally. The long-term goal of the REC
is to develop independent ADRD researchers. The Aims of the REC are to: (1) Create and evaluate a
comprehensive training program in ADRD research for trainees from diverse disciplines at Washington
University. The REC will provide training in a set of core research competencies using individual development
plans to address diversity in training and stage of career development. (2) Develop a comprehensive mentor
training and support program for junior and senior faculty in ADRD research, focused on training investigators
to mentor underrepresented minorities (URM). (3) Increase recruitment, training, and success for
underrepresented groups, women, and people with disabilities. Trainees will have access to mentored
research, didactic training, seminars, national and international meetings, residency programs with the Knight
ADRC Cores, externships, short training programs, and career development programming. They will be
integrated into Knight ADRC research teams. Mentors will receive comprehensive training, including in how to
mentor URM trainees. We will focus on recruiting and retaining URM trainees along the training continuum
through a series of outreach programs and through partnerships with strong training programs at the University
of Rochester and Meharry Medical College. Upon achieving these Aims, we will have a comprehensive
research education component that will capitalize on the rich resources of Washington University to spark
interest in and accelerate the training of diverse trainees in ADRD research.